CTSA Postdoctoral T32 at the University of Michigan

Project Summary
The Michigan Institute for Clinical and Health Research (MICHR) at the University of Michigan seeks to develop
a new postdoctoral T32 training program to prepare early-stage postdoctoral fellows for careers in translational
science and research. This two-year program emphasizes training in interdisciplinary team science that crosses
departments and disease states. Recruitment centers on non-clinically trained basic scientists from biomedical,
social, or data science disciplines, with particular focus on individuals from groups traditionally underrepresented
in translational science. We also endeavor to recruit doctoral-level allied health professionals (e.g., postdoctoral
individuals trained in nursing, pharmacy, physical therapy, and social work) that traditionally have had few
options for advanced translational research training. Five trainees are appointed per year. Each trainee has a
structured mentoring team that guides their professional and scientific development. This team includes Scientific
Mentors, a MICHR Advocate from a different field that serves as a neutral third party, and a Near-Peer Mentor.
Trainees and their mentoring team undergo didactic mentor training. Through the following Specific Aims, this
program works synergistically and purposefully with our K12 and predoctoral programs to fully integrate with
MICHR's mission to improve the lives of individuals and their communities through clinical and translational
research: 1) Provide postdoctoral trainees with precision preparation for a career in translational science,
including training on the fundamental characteristics of a translational scientist, participation in a Translational
Immersion Experience with patients, clinicians, and/or policymakers to improve their understanding of the
conditions they study, and through participation in the MICHR Career Development Studio, training in leadership
and practical skills required to obtain and manage a research program; 2) Strengthen and expand the
professional networks of postdoctoral trainees through networking and team science training, one-on-one
interviewing assignments, and frequent networking opportunities with leading content experts; and 3) Prepare
postdoctoral trainees to be versatile communicators with training in critical verbal and visual communication
skills, including communicating via social media and with the press, and participation in MICHR Writing Squads
and its K Writing Workshop to hone their written communication skills. Trainees and mentors also participate in
our new UM1 Inclusion, Diversity, Equity, and Accountable Leadership in Clinical and Translational Science
initiative (IDEAL-CTS). Trainees will have access to the MICHR Implementation ToolBox, a suite of educational
materials to support protocol implementation, and our M-COMPASS career development platform that provides
trainees with self-paced training modules for incorporation into individual development plans. Our expected
outcome is a postdoctoral T32 program that better prepares and equips trainees for long-term success in
conducting translational research and becoming strong leaders within diverse scientific communities that impact
human health.

Public health relevance
Project Narrative The Michigan Institute for Clinical and Health Research at the University of Michigan seeks to develop a new postdoctoral T32 training program to prepare early-stage postdoctoral fellows for impactful careers in translational science and research. Trainees receive personalized support for their training needs, multi-level training to enhance their professional networks, communication and dissemination training for diverse audiences, and training in diversity, health equity, and inclusion. The overall objective of this training program is to help form the next generation of investigators that strive to improve the lives of individuals and their communities through translational science and research.